1/2 Randomized comparison of the Outcomes of single vs Multiple Arterial grafts trial in Women (ROMA:Women)

Project Summary / Abstract
Coronary artery bypass grafting (CABG) is the most commonly performed adult cardiac surgery procedure, and
the standard of care for patients with severe coronary artery disease. CABG can be performed using either
arterial or venous grafts, with arterial grafts being associated with better outcomes in observational studies, but
not in the only published randomized trial. The Randomized comparison of the Outcomes of single vs Multiple
Arterial grafts (ROMA) trial will evaluate whether multiple arterial grafts (MAG) compared with single arterial graft
(SAG) have better outcomes in the general CABG population (84.5% men). Women represent a minority of
patients in CABG trials, and there are important biological and surgical differences between men and women
undergoing CABG, so that ROMA as currently funded will not allow a meaningful assessment of the effect of
MAG in women. However, ROMA provides a unique opportunity to leverage the existing trial infrastructure to
realize the first cardiac surgery trial dedicated to women (ROMA:Women).
By enrolling 2,000 women, we will have enough statistical power to determine 1) the impact of MAG vs SAG on
major adverse cardiac and cerebrovascular events in women undergoing CABG and 2) the impact of MAG vs
SAG on generic and disease-specific quality of life (QOL) as well as physical and mental health symptoms in
women undergoing CABG. Enrolled patients are randomized 1:1 to MAG or SAG. The inclusion and exclusion
criteria, the interventions, outcome definitions and the follow-up protocol are identical to those of the ROMA trial.
The only exception is that the 70 years age cut-off that was used in ROMA and will not be used in ROMA:Women.
ROMA:Women leverages the existing ROMA infrastructure including clinical trial unit, database, case report
forms, randomization system, site training resources, regulatory approvals, network of participating sites, and
study coordinators. The trial primary outcome is a composite including death, stroke, non-procedural myocardial
infarction, repeat revascularization and hospital readmission for acute coronary syndrome or heart failure at a
minimum follow-up of 2.5 years. The secondary outcome is the absolute change in the Seattle Angina
Questionnaire (SAQ) at 12 months compared to baseline. The trial is designed to have >90% power to
demonstrate a 25% relative risk reduction in the primary composite outcome in the MAG group. Generic QOL
(SF-12, EQ-5D), and symptoms (PROMIS-29) as well as key clinical events will also be captured.

Public health relevance
Project Narrative Proposal Title: Randomized comparison of the Outcomes of single vs Multiple Arterial grafts trial in Women (ROMA:Women). ROMA:Women is the first cardiac surgery trial in women and will provide- for the first time- data exclusively on women with coronary artery disease who undergo bypass surgery, a unique and biologically distinct population that has been underrepresented and poorly studied, despite the well-described fact that women have poorer outcomes after coronary artery bypass surgery than do men. Arterial grafting has been studied in men to improve outcomes after bypass surgery, but women currently receive significantly fewer arterial grafts compared with men, largely due to the dearth of evidence on its use in women. ROMA:Women will answer the question of whether multiple arterial grafting will improve bypass surgery outcomes in women, and if so, the results of ROMA:Women will lead to the endorsement of the use of multiple arterial grafts in women by professional societies and their clinical practice guidelines, changing bypass surgery practice in women, and finally improving clinical and patient-reported outcomes in women undergoing coronary artery bypass surgery worldwide.